Optical Imaging of Tactile Information in S1 Cortex

PROJECT SUMMARY/ABSTRACT The goal of this proposal is to investigate how the brain encodes tactile motion processing in the brain. Responses within two different stages of somatosensory cortical processing, primary (SI) and second (SII) somatosensory cortex, will be examined. Central to understanding their functional roles is finding out what distinguishes one area from another. By using simple versus complex stimuli, we aim to distinguish between areas whose responses are closely associated with the physical nature of the stimulus and areas whose responses are invariant and more closely reflect the motion percept. We will employ optical imaging, voltage sensitive dye imaging, BOLD fMRI, single unit recording, and anatomical tracing methods to address these questions. These experiments will elucidate the neural circuitries underlying tactile behavior and attention, understanding that will have clinical relevance for, for example, recovery of function from stroke and development of tactile prosthetics.